Core A -- Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core’s responsibilities include overall leadership of MIDUS as well as oversight of data
collection, management, and delivery of research data. Leadership will be provided by the Principal
Investigator (PI) and Executive Steering Committee (ESC), consisting of the Leaders/Co-Leaders of the
Projects and Cores. They will oversee major decisions regarding implementation and completion of the stated
aims of the U19 and the Ancillary AD/ADRD U01 applications. Primary leadership tasks include: monitoring
progress in achieving funded objectives of the research; nurturing effective and synergistic communication
across Projects and Cores; organizing and hosting meetings among co-investigators, public users, and the
Data Monitoring Committee (DMC); insuring quality control in execution of the research; managing contractual
agreements, allocation of funds, and yearly reporting; and resolving disputes, when needed. Day-to-day
responsibilities are centrally managed by Admin Core Co-Leaders at UW-Madison, including coordination of
data collection across Projects. Four Projects are included in this U19 (Survey, Daily, Biomarker, Genomics)
and three Projects are included in the Ancillary AD/ADRD U01 (Cognitive, Affective Neuroscience, ADRD
Neuroscience). Data for all will be collected (over a 6-year period) that covers the next wave of the Refresher
(MR2) and the Core (M4) national samples as well as targeted African American samples from Milwaukee. The
Admin Core will oversee and field this complex task, which requires careful sequencing of recruitment from
Project to Project, combined with timely communication among Project-specific investigators. Such goals will
be accomplished through an innovative online Administrative Core database system that manages respondent
assignment, participation, and contact information across Projects in real-time. The Admin Core will also create
and deliver to the research community high quality datasets with comprehensive, user-friendly documentation.
These goals will be advanced via metadata conventions and use of cutting-edge technology supported by a
research documentation standard called the Data Documentation Initiative (DDI). Building off these efforts, the
Admin Core will continue to enhance a one-of-a-kind online Portal that aids users with intelligent search
functions, harmonization tools, and custom data extracts, thereby supporting the longitudinal and
biopsychosocial integrative objectives of MIDUS. Sensitive data (such as from Genomics and Neuroscience
Projects) will be made available via restricted access procedures and repositories managed by the Admin
Core. Admin Core Co-Leaders will facilitate public use of MIDUS datasets via presentations and webinars that
describe how to access and work with the NACDA and Portal data. Finally, the Admin Core will oversee and
manage linkages to external data resources to MIDUS, such as regular mortality updates, Medicare records,
geo-coding, medication usage, and occupational descriptors of MIDUS participants.